NCI Community Oncology Research Program (NCORP) Community Sites (UG1 Clinical Trial Required)

The Nevada Cancer Research Foundation (NCRF) was established in 1983 to conduct cancer research.
The NCRF main office is located in Las Vegas with satellite offices in Reno and Carson City, Nevada and
Arroyo Grande, California and Port Huron, Michigan. Over 80% of the oncologists, hematologists and
radiation oncologists in Nevada are investigator members of the NCRF and participate in NCI clinical
trials and projects. NCRF’s primary mission is to provide quality and state-of-the-art cancer treatment in
Nevada through participation in active cancer research studies for the residents of Nevada through
the participation of the local physicians and health care providers. NCRF also has as part of its
mission the provision of high quality, timely data to the NCI Community Oncology Research
Program (NCORP) Research Bases in a research environment that sets the highest standards for
the safety and welfare of the clinical trials’ participants. NCRF will continue to enroll
patients/participants on NCI clinical trials and plans to exceed the required annual 80 new
unique patient/participant accruals evenly distributed between cancer control, prevention, and
screening/post-treatment surveillance trials, and treatment and imaging trials, respectively that
is required for participation in NCORP. NCRF also plans to participate in at least three cancer
care delivery protocols annually and to continue to participate in bio-specimen collection for
biobanks that serve as scientific resources for the NCORP Research Bases. NCRF plans to
actively work with the NCI to develop an integrated community-based research network in
order to reduce the cancer incidence, morbidity, and mortality in Nevada by accelerating the
transfer of newly developed cancer prevention, early detection, treatment, patient management
rehabilitation, quality of life, and continuing care technology. NCRF will involve NCRF staff
and physicians in the scientific and educational activities of the Research Bases and will
participate in studies to enhance participation of racial/ethnic and other underserved
populations underrepresented in research. To accomplish these goals, the NCRF opens the
program for state-wide participation, thereby providing access for participation to the residents
of Nevada.

Public health relevance
This state-wide program (that also has 3 out-of-state affiliates) provides access to cancer research in prevention, screening, post-treatment surveillance, treatment, imaging, biospecimen collection, health-related quality of life studies, cancer control, cancer care delivery research, and cancer disparities to all interested professionals from varied medical and academic disciplines for state-wide participation, thereby providing access for participation in NCI clinical trials to Nevada residents.